International Symposium on Nutritional Aspects of Musculoskeletal Health

Summary:
Age-related osteoporosis and low bone mass and sarcopenia present health risks,
decreased mobility, and increased fatality rates worldwide. Dietary and physical activity
recommendations for the prevention of osteoporosis and sarcopenia are more
acceptable due to safety and minimal or no side effects compared to pharmacological
therapies. Prevention through lifestyles that have a strong evidence base for
effectiveness and safety may be a better strategy for healthy aging, but prevention must
be seen as a lifelong commitment for optimal outcomes. The 11th edition of the
International Symposium for Nutritional Aspects of Musculoskeletal Health (ISNAMH) is
being planned for April 29-May 1, 2024 at Hotel del Coronado in San Diego, California.
This is the first time this meeting will be held in the USA. It is the only meeting to focus
on the latest research on nutrition and exercise for bone and muscle. The conference
provides an intimate venue where all attendees are together for all presentations,
meals, and social activities. The specific objectives of the conference are: 1) to discuss
the latest science on prevention and muscular skeletal health, 2) to promote the
translation of basic and clinical research with the specific focus on nutrition and
exercise, and 3) to offer mentorship and training for junior scientists. This application is
to provide travel grants to early career and diverse investigators to attend the
symposium and to help defray conference costs. Exposure of early career investigators
to leading experts in prevention and musculoskeletal health and opportunities to present
their work and participate in discussions will enhance their career development.

Public health relevance
PROJECT NARRATIVE This proposal is to support early career and diverse investigators to attend and defray conference costs for the only meeting focused on prevention of musculoskeletal disorders throughout the lifespan.